Boston University-University of Liberia Partnership to Enhance Emerging Epidemic Viruses Research in Liberia (BULEEVR)

Abstract/Summary
The Boston University and University of Liberia Emerging and Epidemic Virus Research (BULEEVR) training
program is a collaboration and partnership with key stakeholders in Liberia including the University of Liberia,
College of Health Sciences (ULCHS), Liberian Institute of Biomedical Research, National Public Health
Institute of Liberia, Partnership for Research on Ebola Virus in Liberia, and Research Sustainability Initiative in
Liberia to create research and PhD training opportunities in basic, translational and public health sciences on
emerging pathogens with a focus on viral pathogenesis in Liberia. This renewal will continue our successful
program to train Liberian scientists and create a culture of science amongst the Liberian research community.
Starting in 2019, BULEEVR, in partnership with stakeholders in Liberia, has provided mentorship and training
for seven BULEEVR scholars. Our trainees have exceeded expectations with four matriculating into PhD
programs and one completing a master's degree at BU before matriculating into a PhD program. In addition,
over the last 5 years, during and post-COVID, we organized workshops and seminars that focused on
emerging and endemic infectious diseases that are health concerns for Liberia, as well as journal clubs and
research-in-progress to foster scientific discussions amongst partners. Goals for the renewal include to
continue to support and create scientific career paths for BULEEVR trainees in clinical, translational and basic
science related to virology, immunology and epidemiology, to expand collaborations between Liberian and BU
scientists to create research opportunities in Liberia, to train the next generation of BULEEVR scholars at the
ULCHS, and to collaborate with ULCHS to assure robust in-country PhD training programs. A priority for
BULEEVR and ULCHS for the next cycle is to support research and training on emerging infectious diseases
in Liberia to minimize training time outside of Liberia and assure a smooth and mentored transition from PhD
training towards independence with sustainable research projects.
Aims for BULEEVR are: 1) increase research competencies by training Liberian scientists in basic,
translational, and clinical sciences with a focus on emerging and endemic pathogenic viruses; 2) assist with
implementation of PhD training at ULCHS; and 3) foster collaborative research in emerging and endemic viral
diseases to support PhD training and develop independent careers in Liberia. Successful completion of these
aims will build a community of Liberian scientist including the next generation of teachers, research leaders
and mentors that will support a culture of science and in-country training opportunities for PhD-level Liberian
researchers.

Public health relevance
Narrative The Boston University and University of Liberia Emerging and Epidemic Virus Research (BULEEVR) training program is a collaboration and partnership with key stakeholders in Liberia including the University of Liberia, College of Health Sciences, to create research and PhD training opportunities in basic, translational, and clinical sciences on emerging pathogens that are agents of concern in Liberia.